Insulin increases nerve-mediated bronchoconstriction in obesity-related asthma

Project Summary
Obesity increases both the incidence and severity of asthma. Obesity-related asthma is associated with more
frequent symptom exacerbations and hospitalizations, which respond poorly to current asthma medications
leading to increased healthcare costs and decreased quality of life. The molecular mechanisms of obesity-related
asthma are yet to be defined, making effective prevention and management of this disease difficult.
Parasympathetic and sensory nerves control airway tone and mediate reflex bronchoconstriction. This proposal
builds on our previous discoveries that 1) increased insulin, associated with obesity, causes airway
hyperreactivity mediated by the vagus nerve in obese rats, 2) that asthma severity is associated with
increased density of sensory nerves in the lung, and 3) that obese mice with high levels of insulin have
increased reflex bronchoconstriction and increased sensory innervation supplying airway epithelia.
Thus, we hypothesize that increased insulin, as seen in obesity, potentiates airway hyperreactivity by changing
both sensory and parasympathetic nerves, and that these changes are mediated by insulin receptors on airway
nerves. We propose to test whether airway hyperreactivity in obese mice is mediated by increased activation of
sensory nerves or parasympathetic nerves or a combination of both, and identify how insulin may change neural
control. We will also measure insulin-related changes in airway parasympathetic and sensory nerve structure
and density, and changes in neurotransmitter expression and release. Finally, we will identify cell signaling
pathways by which insulin promotes sensory innervation and neurotransmitter expression. This project uses
cutting edge, innovative techniques developed in our labs, and will significantly increase our understanding
of underlying mechanisms by which obese patients with increased insulin are more prone to have asthma with
increased severity. The long-term goal of the proposed research is to facilitate identification of novel therapeutic
targets for prevention and treatment of obesity-related asthma.

Public health relevance
Project Narrative Obesity increases incidence and severity of asthma, but the underlying mechanisms remain unclear. This study will investigate the role of increased insulin, which is common in obese individuals, in obesity-related asthma, and identify the mechanisms by which insulin alters the function and architecture of nerves in lungs. Our results will help identify novel targets for prevention and treatment of obesity-related asthma, benefiting millions of patients while reducing treatment costs.